Cell Isolation and Organ Function Core

Cell Isolation and Organ Function (CIOF) Core
The central theme of the CardioPulmonary Vascular Biology (CPVB) COBRE is to facilitate high impact vascular
biology research and enable investigators to develop insights into basic mechanisms of vasculopathies and
translate these findings into prevention or treatment for heart, lung, and vessel diseases. An increased
understanding of the mechanisms regulating vascularization and repair may lead to unique approaches to
interrupt disease pathogenesis or to promote or enhance cardiopulmonary vascular and vessel restoration. The
Cell Isolation and Organ Function (CIOF) core provides a unique skill set and expertise to Rhode Island vascular
biologists by providing quality assurance in isolation, characterization, and propagation of vascular derived cells
and fibroblasts and cardiopulmonary ex vivo organ function analyses. The centralization of the cell and ex vivo
organ isolation, characterization, and function measurements has helped by standardizing technique and
reproducibility, and in turn provided investigators the technical expertise, thus, minimizing variability and
providing uniformity in data acquisition for CPVB investigators. The services provided by the CIOF Core have
permitted the Investigators to focus their efforts on aspects of their research endeavors related to experimental
design, execution and interpretation. During Phase I and II, the CIOF core assisted 78 unique users, provided
5366 services, and performed ~$53,000 worth of services in year 9. Further, CIOF provided training for 36
individuals and provided data analyses for 370 requests (despite pandemic shutdown). The specific aims of the
CIOF core are to: i) offer effective and reproducible services in cell isolation and ex vivo organ function; ii)
acquire, establish, and disseminate technologies and instrument capabilities to provide state of the art research
tools for the scientific community; iii) work with IDeA programs in Rhode Island (RI) and other states to foster
scientific networks and collaborations by providing technical services to enhance research productivity.; and iv)
maintain a robust line of services that meet the research needs of the scientific community. The CIOF core will
continue to support and enhance vascular biology research, including for new pilot project investigators and the
scientific community, in developing, facilitating, implementing, and performing technical services to impact the
research productivity of our IDeA colleagues and collaborators.